EasyVis: Flexible, immersive three-dimensional laparoscopic surgical visualization through multi-camera arrays

Abstract
Laparoscopic or “minimally invasive” procedures are frequently performed in surgery today. It provides
numerous clinical benefits to patients and has become the gold standard surgical procedure for many
intraabdominal and thoracic procedures. Existing laparoscopes provide visualization of the operative field
through a video camera inserted into the patient’s abdomen. It occupies a dedicated laparoscopic port and
requires a camera operator to maneuver and navigate the camera for visualization. The field of view is narrow
and the depth of the scene is difficult to infer. To facilitate surgery, the camera needs to be in proximity to the
operative field, making it prone to smudging, fogging, and splatter that may obscure visualization and require
cleaning. The position of the camera may also interferes with the operating surgical instruments.
To address these deficiencies associated with current laparoscopic visualization, in this project, we will
develop a paradigm-shift, integrated, panoramic, flexible, immersive 3D laparoscopic visualization system
called EasyVis that could significantly improve the efficiency of laparoscopic surgery. EasyVis directly
integrates multiple microcameras and their peripherals including light sources and miniaturized projectors with
the surgical ports. It provides an uninterrupted, intra-abdominal, flexible, and immersive 3D view from arbitrary
virtual viewpoints and viewing angles, and close-up 3D visualization of any specific area, all under direct,
hands-free, easy and full control of the operating surgeon through voice commands, eliminating the need of
camera navigation. EasyVis does not occupy any extra surgical port and solves the problems associated with
smudging, fogging and splatter, and interference with and occlusion of instruments. With EasyVis, the surgeon
is provided with enhanced visualization (better quality, easy control) and less interruption due to laparoscope
manipulation during the operation.
Three specific aims will be pursued. First, we will develop an imaging system including heterogeneous
microcamera arrays, light sources, and miniature projectors. This imaging system provides flexibly selectable
viewpoints and viewing angles with auto-focus and zooming capabilities and real-time scene stabilization. A
system that can deploy the imaging system through a surgical port will also be developed. Second, we will
develop algorithms to achieve flexible global and local views, and immersive, any-view 3D visualization, all
through a human-computer interface worn by the operating surgeon. Third, we will validate our laparoscopic
visualization system with inanimate and animal models.

Public health relevance
Public Health Statement Laparoscopic surgery has continued to evolve and is now the gold standard approach for the majority of abdominal operations, offering numerous clinical benefits to patients. The current paradigm has many drawbacks in the visualization of the surgical field, causing lower operative efficiency. Our goal is to overcome these drawbacks and create a new paradigm in laparoscopic visualization by developing a flexible-view, immersive, three-dimensional imaging system. As a result, laparoscopic operative efficiency will be significantly improved.